NERVE AND MUSCLE INTERACTIONS IN AMYOTROPIC LATERAL SCLEROSIS (ALS)

ALS is a progressive disorder of motor neurons which results in skeletal muscle degeneration. We will study whether there are abnormalities at the neuromuscular junction that interfere with reinnervation.